Discovery of solubilizing side chains for in vivo release of diverse drug classes using the Click Activated Protodrugs (CAP) platform

Abstract
Tambo is developing a platform to activate drugs at specific sites in the body, thus enhancing their efficacy while
minimizing systemic toxicity and adverse drug events (ADEs). Most drugs distribute throughout the body; due to
lack of specificity for the pathological site, high doses are required to achieve effective therapeutic
concentrations, causing toxicity and ADEs in healthy tissues. Each year, there are ~1.2 million reports of ADEs
in the U.S., with overall costs of ADE-related morbidity and mortality thought to exceed $177 billion. ADEs also
contribute to the 90% failure rate of drug candidates. Common prodrug approaches to overcome these critically
limiting ADEs rely on biological or physiological factors, such as selected biomarkers, enzymatic activity, altered
pH, or reactive oxygen species, which have found limited success due to inherent variability among patients.
Tambo’s Click Activated Protodrugs (CAP) platform was designed to achieve higher concentrations of active
drugs at specific pathological sites while minimizing systemic toxicity using an activation method independent of
native biological processes; thus the approach is not affected by variations across patients. The platform also
enables the reinvestigation and repurposing of drug candidates that may have previously been shelved due to
off-target effects. A CAP therapeutic consists of 2 components: 1) a tetrazine (Tz)-modified activating agent that
is not therapeutically active but is targeted to a disease site; and 2) a systemically administered trans-cyclooctene
(TCO)-modified payload (a protodrug) with attenuated activity/toxicity. At the target site, the activating agent
selectively and rapidly captures the protodrug via a bioorthogonal click chemistry reaction, followed by local
release of the payload. One challenge the CAP platform has encountered is that the low solubility of certain
protodrugs limits the feasible dose to subtherapeutic levels. To address this, the Phase I project successfully
synthesized a selection of TCO-modified protodrugs carrying different solubilizing groups, including branched
amino acids, linear PEG chains, and both positively and negatively charged groups. Solubility of a paclitaxel-
based protodrug reached 16 mg/mL in an aqueous formulation buffer; free paclitaxel requires a toxic
cremophor/ethanol mixture to be formulated. Solubility of an exatecan protodrug was similarly high, enabling
high doses of each protodrug when tested in vivo. The protodrugs were tolerable in mice, and when the exatecan
protodrug was tested in a murine tumor model with a biopolymer targeting agent carrying the activator, the tumors
were completely eliminated. Phase II aims to further advance the CAP platform and to demonstrate its modularity
by undertaking three specific aims: 1) synthesizing and characterizing protodrugs from novel therapeutic classes,
2) confirming in vitro and in vivo efficacy of developed protodrugs with a targeting agent, and 3) undertaking
toxicology studies of a lead protodrug with a HER2-targeted activating agent. Phase II success will be defined
by developing new protodrugs that translate to tissue-targeted efficacy and attenuated toxicity in vivo. Ultimately,
the CAP platform could be used to develop better treatments for a wide range of disease indications.

Public health relevance
Narrative Tambo is developing a platform to activate drugs at a specific site in the body, thus enhancing their efficacy while minimizing systemic toxicity and adverse drug events. Phase I synthesized a selection of protodrugs, demonstrating favorable solubility in formulation, tolerability in mice, and effective action in a murine tumor model, and Phase II will advance the platform and demonstrate its modularity using several additional classes of therapeutic agents. Ultimately, Tambo’s platform could be used for site-specific activation of drugs to improve the efficacy and reduce the side effects of treatment for a wide variety of diseases and conditions.